Multi-modal Tracking of In Vivo Skeletal Structures and Implants

PROJECT SUMMARY
The goal of the parent project is to develop an extensible, open-source software program for image-based
skeletal and implant motion tracking that will compute six degree-of-freedom skeletal kinematics from biplane
videoradiography (BVR), 3DCT, or 4DCT image datasets. The parent project partners teams at three academic
institutions with software engineers at Kitware, Inc., an experienced and extremely capable open-source
software development company, to refine and enhance Autoscoper, an existing open-source BVR software
program, and integrate it into the Kitware-managed 3D Slicer ecosystem to yield SlicerAutoscoperM (SAM). In
this project supplement we propose a new collaboration with research software engineers at Brown University
to update and extend an existing online system designed to manage image-based zoological kinematic data –
the X-ray Motion Analysis Portal (XMAPortal) – to create to create the Human Motion Analysis Portal
(HMAPortal), a parallel system for managing and sharing SAM-compliant human kinematic data. The inputs for
SAM consist of 10 or more files generated from 16 or more raw data and calibration files, and most of these files
have associated metadata that are essential for analysis with SAM, such as video frame rate and CT voxel
dimensions. It is crucial the files for SAM are organized in a standard format. This is especially important for the
open sharing of human kinematic datasets among research groups, which is a major long-term goal of the parent
project. When we wrote the parent proposal, we recognized that data management and sharing would present
challenges, but developing those solutions was beyond the scope of our SAM software development. Updating
and extending the XMAPortal to create the HMAPortal will make SAM datasets more findable, accessible,
interoperable, and reusable, i.e., compliant with FAIR principles for data management and stewardship. The
proposed project supplement falls within the scope of the parent project because managing and sharing SAM
data among independent lab testing sites is part of the parent project's specific Aims 2 and 3. Development of
the HMAPortal will create a much-needed template for the organization of legacy and new datasets (data and
metadata), storage architecture, and data access tools. The specific Aims of this supplement are to: 1)
collaborate with professional software engineers at Brown University to use robust software engineering
practices to re-engineer and adapt the existing XMAPortal code to create the HMAPortal, a repository for SAM
human kinematic datasets; 2) create HMAPortal data upload (HMAPortalupload) and download (HMAPortaldownload)
plugins to translate and standardize datasets, thereby making these and all future datasets conform to FAIR data
principles: findable, accessible, interoperable, and reusable; and 3) engage with the research community to
develop consensus on data structures for the HMAPortal, through workshops that are already planned as part
of the parent project.

Public health relevance
Narrative Because musculoskeletal disorders affect over 250 million people worldwide, the ability to accurately measure joint and implant motion in human subjects performing activities of daily living is necessary to advance our understanding of normal joint function, disease-related changes, and the effects of treatment such as joint replacement. We are developing software for state-of-the-art image-based bone motion and implant tracking that will compute skeletal and implant motion from various imaging modalities. The aim of this supplement is to develop an open-source database to standardize the storage and export of data files for the motion software program. The database we develop will broaden access to image-based motion analysis tools and simplify the sharing of novel datasets, which will hasten translation to clinical practice.